Administrative Core

Massachusetts Alzheimer’s Disease Research Center: Administrative Core
The Administrative Core of the Massachusetts Alzheimer’s Disease Research Center (MADRC) leads the
Center’s efforts to map strategic and operational plans to understand the drivers of clinical progression in
Alzheimer’s disease and related disorders (ADRD). The Administrative Core sets the strategic priorities and
outlines the tactics: We created the strategic plan for this application, with a focus on two closely related topics:
understanding clinical progression and its relationship to markers of disease progression, and developing novel
techniques to improve measurement of both. We coordinate efforts of the various components of the Center
with each other, and coordinate planning for optimal utilization of resources within the Center and by
leveraging institutional capabilities. We also act as an interface for the Center to optimize connections with the
lay public, with institutional stake holders, and with national efforts. We take an active role in future planning,
faculty recruitment and retention, and training of future leaders. The Administrative core coordinates
interactions to develop trans-ADRC and other outside research projects. We oversee the research and grant
administrative processes, including human subjects, animal welfare (if needed by a Developmental Project),
scientific integrity, data and sample sharing, and financial policy requirements. We ensure timely and complete
communication with NACC, timely and complete submission of samples to NCRAD, and continued
participation in NIA summits and similar national forums.
The Director is assisted and advised by an Administrative team that runs day to day operations and
provides fiscal and regulatory oversight, an Executive Committee, composed of Core leaders, a Data-
Operations Committee charged with operational efficiency, an Internal Advisory Committee of institutional
leaders, and by a series of special purpose committees, including Developmental Projects, Clinical Research
Steering Committee (which also oversees clinical trials interactions), Tissue Distribution and Biofluid
Distribution Committees, Minority Inclusion Program Committee, the Community Advisory Board, and a REC
Steering Committee. We are also advised by and assisted by an External Advisory Committee (EAC) that
provides input on all aspects of Center activities. Importantly, we recruit, select, monitor, and mentor the
recipients of the Developmental Projects program. The Chair of the External Advisory Committee also chairs
the selection committee; we use this program to further enhance the growth of new science and new
investigators, as another tool to build the future of our program. In sum, the Administrative Core provides
leadership and support for both the broad efforts of the Center and support for the day-to-day activities that
allow the Center have a maximal impact in our fight against ADRD.